Genomic surveillance for antimicrobial resistance in animals

Project Summary/Abstract
There is a growing need for monitoring antimicrobial resistance in animals in order to protect the safety of both
people and animals. Capacity for bacterial whole genome sequencing in veterinary institutions supports the
mission of FDA to ensure the safety of our nation's food supply and protect public health by enabling real-time
monitoring of isolates. In this proposal, we request funding to maintain capacity for our bacterial sequencing
services for FDA. The capacity to perform advanced molecular characterization of bacterial isolates in a
reliable manner is critical to our ability to respond quickly to suspected microbiological contamination and
monitor antimicrobial resistance in animals and feed. Importantly, having this capacity fills a critical surveillance
gap by monitoring live animals for antimicrobial resistance. In addition to serving as one of the sequence
reference labs, the Goodman laboratory at Cornell has provided analytic support to the program office and
mentorship to the other laboratories by providing validation, methods, and Quality Assurance documentation
for these procedures. The proposed studies will have important impacts for both human and animal health and
will improve the capabilities of Vet-LIRN to perform effective surveillance for food-borne pathogens.

Public health relevance
Project Narrative Testing for antimicrobial resistance in sick animals is needed to support the mission of FDA to protect public health. In 2017, FDA Vet-LIRN launched a surveillance initiative including whole genome sequencing as a key component for mitigating the lack of standardization in antibiotic susceptibility testing in their network. Sequencing methods are now standardized across six laboratories in the network, including at Cornell, and we are requesting support for these activities for the next five years.